Nutrition, terminal NAD metabolites and cardiovascular disease

SUMMARY
In this application, we used untargeted metabolomics as discovery platform to structurally identify and
characterize an unknown metabolite whose levels in plasma in a Discovery Cohort are strongly associated with
incident risk for development of cardiovascular disease (CVD), and major adverse cardiovascular events
(MACE = myocardial infarction (MI), stroke or death). Extensive chemical structural elucidation efforts
revealed the “analyte” was in fact a pair of rarely studied structural isomers that serve as terminal metabolites
of NAD+ metabolism, namely 2PY and 4PY. Vitamin B3 is niacin (nicotinic acid, and nicotinamide), and is
integrally linked to both NAD+ and cellular energy metabolism. This proposal integrates nutrition and
metabolism data in both health and disease. It also explores mechanisms of micro-nutrient processing
(NAD+/niacin) and its impact on metabolism, pathophysiological pathways and disease outcomes.
Preliminary data indicate the terminal metabolite, 4PY, but not its structural isomer 2PY, is clinically associated
with CVD risks, and preliminary cellular and disease model studies suggest 4PY directly fosters vascular
inflammation and heightened thrombosis potential. We will use a variety of approaches to explore the
metabolism, biology and (patho) physiological links between 4PY and CVD relevant phenotypes. Our studies
also suggest that a specific genetic variant, coupled with dietary tryptophan, can give rise to both enhanced
4PY levels, and vascular endothelial cell activation, pro-inflammatory gene programs, and heightened
atherosclerosis and thrombosis potential. The present studies have significant potential public health
importance for many reasons. They identify a new potential contributor to residual CVD risks independent of
traditional risk factors. They also call for reassessment of the safety of cereal fortification, a practice
institutionalized in the US since WWII. Finally, the present studies may help explain the “niacin paradox”
wherein large doses of niacin used to lower LDL cholesterol, failed to match expectations in clinical trials based
on the degree of LDL lowering.

Public health relevance
Project Narrative Niacin, or vitamin B3, is an essential nutrient linked to NAD+ metabolism, and critical to energy metabolism. It must be consumed through the diet since we are unable to synthesize or store it, and most metabolic pathways related to niacin and NAD+ are anabolic (involved in synthesis, or reclamation/salvage of the molecule). This application explores the potential relationship of 4PY, a terminal metabolite of NAD+ and niacin metabolism, with cardiovascular health, using analytical, genetic, molecular, cellular and physiological approaches, and preclinical models of disease.